Immune Analytics Core (IAC)

ABSTRACT - IMMUNE ANALYTICS CORE (IAC)
The Immune Analytics Core (IAC) is an essential component of this P01 Program by developing and providing
relevant immunogens and by performing standardized assays to assess vaccine-induced immune responses in
rhesus macaque and human studies proposed in Projects 1 and 2.
To support the overall goal of the Program “Translating germline-targeting HIV Env SOSIP immunization of
infants: targeting bnAbs in early life”, the IAC will pursue three Specific Aims. Aim 1 will focus on the
development and production of germline-targeting or standard SOSIP trimers. The trimers will not only be
essential for the proposed immunization, but also for the analysis of vaccine-induced antibody responses. The
trimer production team leader, Dr. John Moore, is an expert on trimer design both for preclinical and clinical
studies. Dr. Moore’s long-standing track record in trimer development and optimization is deemed critical for
the success of the Program. The immunogens generated in Aim 1 will also be a critical tool for the analysis of
vaccine-induced immune responses in Aim 2 of the IAC. Aim 2 will define the phenotype of vaccine-induced
HIV Env-specific B cells by flow cytometry, with a particular focus on memory B cells targeting the CD4bs and
enumeration of plasma cells. At selected time points, we will perform single cell BCR sequencing to define the
somatic hypermutation rate and the heavy and light chain usage of bNAbs. The induction of bNAbs will be
correlated to follicular T helper cell responses to the various vaccine regimens tested in Project 1 and by the
combination of active and passive immunization in Project 2. Expanding upon data in Aim 2, Aim 3 will apply
electron microscopy-based polyclonal epitope mapping (EMPEM) to identify the epitope specificity of vaccine-
induced antibodies. Immune sera from vaccinees will be examined by EMPEM to track antibodies to the CD4
binding site. High resolution analysis of the CD4bs responses will provide information on the molecular
features of such responses. Additionally, the generated data can be used to further optimize vaccine
candidates to reduce unwanted responses and enrich for on-target functional antibodies to neutralizing
epitopes. The approach is to subject polyclonal antibody complexes to negative stain EMPEM, determine the
most interesting candidates and apply cryoEM analysis to predict the sequences of the antibodies using a
combination of the cryoEM data and B-cell sequencing data. To ensure rigor and reproducibility, all methods in
Aims 1-3 are well established and will be conducted according to standard operating procedures with built-in
quality control measures. In summary, the IAC will provide immunogens and assess vaccine immunogenicity
and the maturation of bNAbs by applying complementary immune, molecular, and structural biology
technologies and analytic tools.